Post-baccalaureate Research and Education Program

The University of New Mexico Postbaccalaureate Research and Education Program (UNM PREP) is a biomedical research training program, focused upon Minorities and socioeconomically under-represented individuals who plan to enter a PhD program. Through a series of defined objectives, we shall: recruit high-quality under-represented Scholars to our program; develop and realize individualized training plans to provide laboratory research experience and academic training to improve the skill set of the Scholar; provide additional training modules to develop the professional skills of the Scholar; provide support and training in the successful application of the Scholars to PhD programs; investigate the parameters impacting graduate school retention; and utilize these data to improve graduate training at UNM. We anticipate that the results of this training will be to increase the numbers of under-represented individuals in the sciences.

Public health relevance
The relevance of this project to human health is through the direct training of individuals in biomedical science fields, and their subsequent strong performance in PhD programs. The Scholars that we train will enter the biomedical work force and contribute to understanding and ameliorating human disease.